PRE/POSTPUBERTAL DETERMINANTS OF BONE MINERALIZATION IN JRA

The objective of this study was to determine the extent of significant osteopenia in post-pubertal females with juvenile rheumatoid arthritis (JRA) not treated with corticosteroids compared to controls and to identify disease and anthropometric variables related to bone mineralization in this population. Total body bone mineral density did differ between the JRA and control groups. Osteopenia, a precursor to the development of osteoporosis exists in over 15% of both populations of post-pubertal U.S. females who have achieved peak bone mass. Subsequent study is needed to determine what additional factors (e.g. dietary intake and physical activity) may further predict total body bone mineral density in post-pubertal JRA patients and healthy controls.